Species-transcending prevention of mosquito vector infection

Malaria remains a leading cause of human disease and suffering worldwide, with more than 249 million cases
of malaria resulting in approximately 608,000 deaths in 2022. The majority of cases are caused by several
species of vector-borne parasites of the genus Plasmodium, with Plasmodium falciparum (Pf) and Plasmodium
vivax (Pv) accounting for nearly all human infections worldwide. The development of effective vaccines faces
significant hurdles from the diversity inherent to multiple species of causative agents, along with diversity
existing within species. Vaccines that can provide efficacy against more than one species of Plasmodium do
not exist, therefore accounting for the diversity of malaria currently requires a multi-antigen or multi-vaccine
approach. Given the infrastructure and economic constraints of delivering a vaccine in endemic areas, a
bespoke vaccine approach local to an area is not feasible and remains a significant roadblock to global
eradication efforts. Our recent work on vector transmission biology has led to the discovery of a novel vaccine
target called HAP2p which, together with its known paralog HAP2, opened a new path for vector stage vaccine
development. HAP2 and HAP2p vaccines would block infection of the mosquito vector, breaking the life cycle,
and thus, would be powerful tools for eradication. Importantly, we provide experimental proof of concept that
antibodies against these two targets can mediate transmission reducing activity (TRA) across the species
divide and are active against both Pf and Pv, raising the possibility of developing a universal transmission
blocking vaccine (TBV) with worldwide coverage and overcoming the major barriers noted above. We propose
an integrated research program that combines world-class expertise in antigen and mAb technologies, malaria
vector stage biology, and structure-guided vaccinology. We aim to develop potent TRA-mediating monoclonal
antibodies (mAbs) defined by their ability to block vector infection with species-transcending activity. In parallel,
we will characterize human naturally acquired immunity against these mosquito stage targets in subjects with
previous malaria infection. Potent mAbs, derived from both humans and mice, will serve as prototypes for
structure-guided vaccine design. We will define the structural features of epitope recognition which we will use
to optimize our antigens, culminating in new structurally designed HAP2 and HAP2p vaccines that elicit
exceptionally potent species transcending vector transmission blocking. This comprehensive approach has
proven exceptionally powerful in developing potent vaccine candidates in a variety of species, and we
hypothesize that this structural vaccinology approach can optimize HAP2 and HAP2p vaccine candidates with
superior stability, antigenicity, and vaccine efficacy. If successful, this research will culminate in the first pan-
Plasmodium species vaccine candidate, one that can be deployed worldwide. A single optimal universal
transmission blocking vaccine would provide an extraordinarily powerful eradication tool which would be
transformational in the fight to eradicate malaria.

Public health relevance
NARRATIVE Malaria is caused by several different species of parasites of the genus Plasmodium, with Plasmodium falciparum and Plasmodium vivax accounting for nearly all infections worldwide. The diversity of malaria parasites complicates vaccine development, and historically has required the development of many different vaccines to account for species and strain differences which has hampered and vastly complicated efforts to deploy effective vaccines. We recently discovered that a novel vaccine candidate can elicit antibodies that block transmission of both malaria species, and here we aim to develop a single vaccine that can elicit transmission blocking activity for both species of Plasmodium.